The Role of TMEM106B in FTLD-TDP Pathogenesis

PROJECT SUMMARY/ABSTRACT
Alzheimer disease and related dementias (ADRD) comprise a group of neurodegenerative diseases
characterized by progressive decline of cognitive, behavioral, and/or motor function. These conditions place a
significant burden on patients, families, and the healthcare system. Among the ADRDs is frontotemporal
dementia (FTD), with approximately half of FTD cases characterized pathologically by frontotemporal lobar
degeneration with TDP-43 pathology (FTLD-TDP). Single nucleotide polymorphisms (SNPs) in TMEM106B are
known to alter risk of FTLD-TDP. TMEM106B is a protein localized to late endosomes and lysosomes and has
been reported to play a role in endolysosomal trafficking and brain myelination. Only one TMEM106B SNP
causes a coding change, altering the amino acid at position 185 from threonine to serine (T185S). The TT185
haplotype is associated with significantly increased risk of FTLD-TDP relative to SS185. The SNP is also in high
linkage disequilibrium with other TMEM106B SNPs, marking the coding change as a potential mechanism behind
TMEM106B’s modulation of disease risk. The coding SNP of TMEM106B has not been studied extensively,
though the coding change has been reported to alter protein half-life and autophagic flux in the cell. Recently,
four groups published the discovery of TMEM106B amyloid fibrils in sarkosyl-insoluble cortical lysates across a
range of neurodegenerative diseases, including FTLD-TDP. In preliminary studies, we have observed that
accumulation of TMEM106B fibrils is positively associated with the TT185 haplotype. We speculate that the
TMEM106B risk haplotype drives fibril formation and endolysosomal dysfunction, both of which contribute to
neuron loss in disease. The studies outlined in this proposal will characterize the biological consequences of
TMEM106B fibril formation in the diseased human brain and investigate TMEM106B haplotype-specific
differences in endolysosomal function in a new cell model system. In Aim 1, we will identify protein interactors of
TMEM106B fibrils in postmortem FTLD-TDP and non-diseased brains to test the hypothesis that TMEM106B
fibrils exhibit disease-specific interactions that drive neuron loss. In Aim 2, mechanistic studies will be performed
in novel, isogenic iPSC-derived neuron models stably expressing TMEM106B coding variants to test the
hypothesis that the TMEM106B risk haplotype impairs endolysosomal function. We will also assess mechanistic
relationships between TMEM106B and top interactors identified in Aim 1, and how they may vary with
TMEM106B haplotype. We anticipate that this work will help identify novel protein targets to investigate or target
for therapeutic development.

Public health relevance
PROJECT NARRATIVE Single nucleotide polymorphisms (SNPs) in TMEM106B have been reported to alter risk of frontotemporal dementia, and TMEM106B protein aggregates were recently discovered in postmortem brains of individuals with FTD. This proposal aims to improve our understanding of how TMEM106B SNPs alter protein function, and to define disease-specific interactions of TMEM106B fibrils. Together, these data will inform the development of new therapeutic strategies and/or protein targets to combat FTD.